Motoric Cognitive Risk Syndrome: Refining Treatment Strategies and Testing Feasibility to Personalize Treatment for Older Veterans

Dementia poses a significant challenge to aging Veterans. Yet, dementia often has a long preclinical phase
which may be the optimal window for impactful preventative care. Motoric Cognitive Risk syndrome (MCR) is a
preclinical dementia syndrome characterized by slow gait speed and subjective cognitive complaints. There
are limited preventative treatment options for Veterans with MCR. However, physical activity-based treatments
that improve both mobility and cognition are likely to be beneficial for older Veterans with MCR. Functional
Power Training (FPT) and Music-Based Digital Therapy (MBDT) are evidence-based treatments that improve
walking and may be effective treatments for Veterans with MCR. FPT and MBDT potentially enhance mobility
through different mechanisms. However, there is individual variability in responses. Individuals who are not
responding to a given treatment may benefit from different treatments or combinations of treatments,
highlighting the need for a personalized adaptive approach. This 5-year Career Development Award (CDA-2)
builds on my prior work as an exercise physiologist delivering exercise treatments to older adults and the
formative work from my 2-year VA Rehabilitation Research and Development CDA-1. The CDA-2 will conduct
a pilot Sequential Multiple Assignment Randomized Trial (SMART) to identify effective adaptive interventions
using FPT and MBDT (n=54). The proposed study will 1) develop and refine adaptive intervention manuals for
use with older Veterans with MCR; 2) assess the feasibility and safety of adaptive interventions through a pilot
SMART; and 3) evaluate the acceptability of adaptive interventions and SMART design. Successful
completion of this CDA-2 will provide the groundwork for subsequent fully powered SMART and Adaptive
Intervention trials contributing to evidence-based personalized treatments. This will advance my research
career focusing on developing and testing innovative adaptive dementia prevention treatments for older
Veterans who are at high risk for transitioning to dementia. Specialized training objectives to accomplish these
research aims and the long-term career goal are 1) acquire a foundation for implementation science, 2) gain
expertise in advanced programmatic clinical trials (Adaptive Interventions & SMART), 3) advance skills in
mixed methods, qualitative analysis, and interviews, 4) expand my knowledge and experiences in rehabilitation
science and integrate with implementation science, 5) enhance grant writing, scholarly dissemination, and
leadership. I will use the combination of didactic coursework provided by a rich academic research
environment, hands-on research training, and mentorship from a team of experts who can offer extensive
knowledge and support this CDA-2 and my research career.

Public health relevance
Dementia is a growing concern among aging Veterans. This study will evaluate personalized preventative dementia treatments for Veterans at risk for dementia. We will target Veterans with Motoric Cognitive Risk syndrome (MCR), which is characterized by slow gait speed and cognitive concerns (e.g., problems with memory and/or concentration). We will test two therapeutic exercise treatments: one focuses on power training, while the other employs music-based therapy. This study will use a novel study design, Sequential Multiple Assignment Randomized Trial (SMART). Successful completion of this study will lay the foundation for subsequent research trials, contributing to valuable evidence for personalized rehabilitation medicine for older Veterans. Moreover, achieving these milestones aligns with the researcher’s career goal of developing and testing innovative personalized dementia prevention strategies using novel study designs for older Veterans at the highest risk of transitioning to dementia.